Thin, High-Density, High-Performance, Depth and Surface Microelectrodes for Diagnosis and Treatment of Epilepsy

ABSTRACT
The goal of this project is to significantly advance the field of acute and semichronic epilepsy monitoring
using novel, high-resolution electrocorticography (ECoG) record/stimulate grids (4096/256 channels,
respectively) and stereoelectroencephalography (sEEG) depth electrodes (120/8 micro/macro) with full wireless
data and power transfer. This project builds on our previous success in conducting the first-ever human trials for
acute mapping of eloquent brain tissue with multi-thousand channel microelectrode grids. The proposed system
encompasses multiple transformative technological approaches, including: (1) leveraging advanced thin-film
microfabrication on 8” diameter substrates, thus permitting long integrated connectorization from thousands of
channels; (2) exploiting a newly developed platinum nanorod (PtNR) microelectrode technology with excellent
low impedance, high charge-injection-capacity (4.4mC/cm2), stability, and biocompatibility; and (3) using a thin
(~10μm) parylene C substrate that is compliant to brain movements, conformal to brain curvature, and
transparent, permitting easier visualization of brain anatomy during the acute mapping. Further, (4) the grids
developed for this project are modular and can be trimmed to fit different sizes of craniotomies, and (5) this
system offers a new generation of minimally invasive sEEG electrodes with easily reconfigurable microcontact
distribution in different regions of the brain Our proposed system also (6) employs state-of-the-art acquisition
electronics with a miniaturized 1024ch neural interface system-on-chip and radio transmission of data and power,
enabling fully wireless monitoring that eliminates wire externalization, and (7) deploys multi-screen and multi-
window visualization of the whole repertoire of electrophysiological activity, with the option to display and interpret
signals in standard fashion.
Our goal is to demonstrate in the semichronic clinical setting a high-definition display of traditional and
emerging clinical biomarkers for epilepsy monitoring and treatment. To achieve this goal, we will pursue in Aim
1 regulatory input from the FDA and scale our grids under good quality laboratory practices (GLP), and perform
benchtop testing and hardware and software development under a quality management system. In Aim 2, we
will perform semichronic animal testing under GLP to demonstrate safety, tolerability, and efficacy of the new
epilepsy-monitoring system. In Aim 3, we will will perform pre-clinical and human intraoperative recordings with
appropriate IRB authorization. We will pursue FDA clearance for semichronic implants in Aim 4, and transition
Aim 5 to semichronic epilepsy monitoring in patients with intractable epilepsy.
The methods employed in device and system development, surgical approaches, electrophysiology, and data
analysis will not only advance functional and epilepsy monitoring but will also have significant implications for
numerous applications in neuromodulation/therapeutic stimulation, minimally destructive brain-machine
interfaces, and spinal cord stimulation.

Public health relevance
NARRATIVE Epilepsy is now believed to result from aberrant activity of multiple neural “nodes” that together create a self- reinforcing network phenomenon. Standard clinical electrodes used in the diagnosis and treatment of drug- resistant epilepsy do not offer sufficiently fine resolution for microscale interrogation of the epileptogenic networks. This project aims to deliver a fully wireless multi-thousand channel electrode system with large-scale but precise cortical coverage, which will advance our understanding and treatment of epilepsy through analysis of neural activity at an unprecedented resolution, as demonstrated in acute human studies, semichronic animal safety and efficacy tests, and a small clinical trial.